Approximating Mechanisms of Suicide Risk to Innovate Interventions for Mid-to-Late-Life Veterans

The current 2-year career development award (CDA-1) proposal is designed to prepare Dr. Michael
Ruderman, a VA Psychiatrist with foundational knowledge of advanced research methods, for a career in VA
conducting research as a psychiatrist scientist who will advance innovation in suicide prevention and
intervention strategies—identifying and targeting causal mechanisms for suicide that are amenable for
intervention. Dr. Ruderman will accomplish this goal through the pursuit and completion of training activities,
support from an expert mentoring team, and completion of a research project aimed at bridging the gap
between causal inference research methods and clinical knowledge to inform suicide interventions. The CDA-1
project will ultimately generate pilot information about causal factors for suicide risk with refinement based on
expert elicitation for Dr. Ruderman’s submission of a CDA-2 application.
Dr. Ruderman’s proposed CDA-1 project supports VA’s top clinical priority—Preventing suicide.
Moreover, this proposal is directly aligned with VA’s mandate to prioritize research that can help develop
targeted suicide interventions by finding out why certain Veterans are at risk of suicide. Despite VA’s strong
predictive analytics for stratifying Veterans at risk for suicide, the mechanisms leading to suicide are poorly
understood. This lack of knowledge has impeded the innovation of targeted and effective interventions
available. National suicide research agendas urge investigators to leverage existing data and determine
potential causal targets that could define or develop effective suicide interventions. However, few large-scale
databases exist that would have the capacity to harmonize and link to the right breadth and depth of
information to successfully detect causal targets for a rare (yet, profound) outcome like suicide. Thus, this
CDA-1 proposed research leverages Dr. Amy Byers’ (primary mentor on the CDA-1) CSR&D Merit award
project (CX001119), which uniquely formed a longitudinal cohort of 5 million Veterans aged 50 years and older
including, currently, nearly 12,000 suicide deaths and data on demographics, inpatient, outpatient,
medications, labs, and morbidity. The CDA-1 project will expand upon Dr. Byers’ research on late-life suicide
risk looking at prognostic factors and fill a significant gap in the field, causal inference, complementing
predictive analytics in suicide risk research at VA. Furthermore, focusing on mid-to-late-life Veterans is ideal
because it supplies targeted information in this understudied and highly vulnerable group, who have the
highest number of lives lost to suicide (~70% of all Veteran suicide deaths), as well as make up over 70% of
the Veteran population.
Discovering candidates from large secondary data requires an approach that can extract causal
information efficiently while also prioritizing likelihood of clinical utility. Data-driven causal methods have the
potential to do this, but only if such methods are tightly linked with existing clinical and other scientific
knowledge. Therefore, we propose an approach where we: first (Aim 1) utilize causal discovery techniques to
identify preliminary causal candidates for suicide in Veterans aged 50 years and older; and, then, second (Aim
2) develop a protocol to elicit clinical expertise on potential mechanisms of suicide, which will provide
necessary pilot information for a CDA-2 application. Such a biphasic approach ensures expert knowledge is
integrated with computational analysis to maximize likelihood of clinical utility for suicide prevention. To this
end, the aims and training of this 2-year CDA-1 will prepare Dr. Michael Ruderman to submit a CDA-2
application—clearing a path toward an independent research program as a computational psychiatrist, bridging
methods to institute actionable change, reducing suicide risk for Veterans, and empowering their providers.

Public health relevance
Suicide prevention is VA’s highest clinical priority, and, yet, little is known about causal factors and mechanisms for suicide; and, thus, little progress on salient interventions reducing risk of suicide. The proposed CDA-1 will provide necessary and relevant knowledge on causal factors associated with suicide risk in mid-to-late-life Veterans—a subpopulation that encompasses the greatest number of Veteran lives lost to suicide. This project will leverage an existing cohort of 5 million Veterans 50 years and older with multiple linked national large-scale datasets, including national suicide data. The current longitudinal cohort includes ~12,000 suicide deaths and over 20,000 nonfatal suicide attempts. The CDA-1 proposal is directly aligned with VA’s mandate to prioritize research that helps to develop targeted suicide interventions by finding out why certain Veterans are at risk of suicide and eliciting expert knowledge to improve upon the clinical utility of such information; ultimately, advancing the current landscape of VA’s suicide prevention and intervention programs.